Investigation of cellular cues for differentiation of ventricular cardiomyocytes

PROJECT SUMMARY
Heart failure is the deterioration of cardiac function in part due to cardiomyocyte (CM) death. In vitro
differentiation of human pluripotent stem cells (hPSCs) into CMs is a key method for developing cell-replacement
therapies for heart repair, due to the heart’s inability to regenerate. Despite improvements in differentiation
efficiencies, current protocols give rise to functionally immature, diverse populations of CM sub-types at different
developmental states leading to unfavorable effects when transplanted in humans. To generate specific, mature
CM sub-types in vitro for heart repair treatment, it is essential to understand the cell fate decisions and
developmental cues that allow a cell to become a particular cell type. A cell’s development is highly dependent
on its environment within a tissue, particularly through cell-cell interactions between distinct cell types. To
understand how CMs are influenced by their environment, we examined the differentiation states of CMs in a 2D
(monolayer) versus 3D (embryoid body) cellular environment. Here, we observed that ventricular CMs (vCMs)
develop more efficiently and CMs exhibit a more developmentally mature cellular state in the 3D environment as
compared to the 2D environment. Additionally, the 3D system contains a more heterogenous cellular
environment and has differing signaling cues versus the 2D system. Therefore, the central hypothesis of this
proposal is that the non-cell autonomous effects of the surrounding 3D cellular environment may
promote vCM differentiation by generating a more in vivo-like environment. Toward this end, we will
investigate the impact of the 2D versus 3D cellular environments on vCM differentiation (Aim 1). Additionally, we
will identify paracrine cues secreted from non-CM cell types that influence vCM differentiation (Aim 2). These
key studies will elucidate the impact of non-CM cell types and their specific molecular cues on the generation of
vCMs, thus allowing for the generation of pure populations of more in vivo-like cell types that can be used for
heart failure treatment and therapeutic development.

Public health relevance
PROJECT NARRATIVE This proposal seeks to examine the role of cell-cell interactions in generating ventricular cell types in a dish that better represents the cell types within the ventricles of the developing human heart. By comparing two different models for ventricular cell type generation that utilize human embryonic stem cells to produce cardiac myocytes, we hope to understand which specific non-myocyte cell types and molecular cues can enhance the production of ventricular cell types. These fundamental studies may offer novel insights into the signals in the developing heart as well as provide possible treatment options for heart failure.